Pathways to successful aging among perinatally HIV-infected and exposed young adults: Risk, resilience, and the role of perinatal HIV infection

Advances in HIV treatment and prevention have led to millions of perinatally HIV-infected (PHIV) and perinatally
HIV-exposed, but uninfected (PHEU) children surviving into adolescence and young adulthood. Young adulthood
can be a precarious developmental period, and PHIV young adults (YA) are at particularly high risk for mental
health problems, risk behaviors, and difficulties achieving adult milestones due to a “perfect storm” of compromised
health, life stressors, and neurocognitive deficits. These risks are exacerbated by inadequately controlled HIV, and
psychosocial stressors encountered by both PHIV and PHEU YA, leading to chronic inflammatory responses that
compromise psychiatric function, neurocognition, and overall health outcomes. For the past 15 years, CASAH has
followed 340 PHIV and PHEU youth (enrolled at ages 9-16 years) living in vulnerable communities in New York
City, documenting risk and resilience across childhood, adolescence, and emerging adulthood. This competing
continuation of CASAH (R01-MH69133-15), CASAH4, will follow this cohort through young adulthood (20s-early
30s), leading to one of the most comprehensive longitudinal data sets on mental health, health risk behavior,
and achievement of adult milestones among PHIV and PHEU YA. Guided by Social Action Theory (SAT),
CASAH4 offers a unique opportunity leverage our unique longitudinal data set to understand the impact of both
lifelong HIV infection and also contextual, social-regulation, and self-regulation determinants of mental health,
health risk behaviors, and adult milestone achievement. In CASAH4 we aim to 1) examine the impact of HIV
infection on behavioral health outcomes (e.g., mental health, sexual risk, substance use, adherence) and
achievement of adult milestones (e.g., education, vocation, independence); 2) examine how SAT-informed risk
and protective factors affect YA behavioral health and achievement of adult milestones; 3) explore trajectories
of behavioral health across adolescence and young adulthood and SAT-informed predictors of these trajectories;
and 4) compare behavioral health outcomes and their SAT-informed predictors among youth across three global
cohorts by PHIV-status at early (9-12 years), middle (13-15 years), and late (16-19 years) adolescence. Building
on our previous work, we will enhance our assessment of adult milestones, psychiatric function, and
neurocognitive function, and will add biomedical health indicators (inflammation and immune activation
biomarkers associated with psychiatric disorders and neurocognitive function) to the HIV RNA viral load and
CD4+ cell count already collected. CASAH has made significant contributions to research on risk and resilience
in PHIV and PHEU youth with 117 publications and 65 scientific presentations, and has directly informed mental-
health and HIV-prevention interventions and service systems in the US and abroad. With a multidisciplinary and
cross-cultural team, we have a unique opportunity to extended our work into young adulthood, to identify
modifiable predictors of behavioral risk trajectories and young adult function, and to inform the development of
timely, targeted, and evidence-based interventions for vulnerable PHIV and PHEU across global contexts.

Public health relevance
The pediatric HIV epidemic is rapidly becoming one of young adulthood with millions of perinatally HIV-infected (PHIV) and perinatally HIV-exposed but uninfected (PHEU) children surviving into young adulthood globally. PHIV and PHEU young adults (YA) face a “perfect storm” of risk factors that can lead to poor behavioral health outcomes and difficulty achieving adult milestones, and PHIV YA may be additionally vulnerable to chronic inflammatory responses (due to inadequately controlled HIV and psychosocial stressors) that compromise psychiatric function, neurocognition, and overall health outcomes. Young adulthood is also a period of significant opportunity to promote healthy development and optimize adult functioning and CASAH4 will contribute to this critical research gap by examining the impact of both lifelong HIV infection and contextual, social-regulation, and self-regulation determinants of mental health, health risk behaviors, and adult milestone achievement to inform the development of timely, targeted, and evidence-based interventions for vulnerable PHIV and PHEU across global contexts.